Core A: Administrative, Career Development, and Research Integration Core

ABSTRACT
The Administrative, Career Development and Research Integration Core of the Center for Molecular
Epidemiology at Dartmouth (“Administrative Core,” Core A) is the driving force that underpins the Center’s
achievements. It will support the Center’s goals of: 1) moving the Center to full independence and sustainability
by enhancing the governance and operational structure of the Center, broadening its reach, and engaging
stakeholders in the research direction and priorities of the Center; 2) advancing the state-of-the-art
Biorepository and Biospecimen Resource Facility Core (Scientific/Technical Core B); and 3) strengthening the
pipeline of talented, diverse molecular epidemiologists by recruiting, mentoring, and providing career
development resources in collaboration with the Pilot Project Program. The Administrative Core will oversee
the strategic direction of the Center and facilitate planning and execution of the Center’s mission by
coordinating and communicating with the leadership, advisory committees, cores, programs, and members,
and guiding how resources will be obtained, prioritized, allocated, and monitored. It will be responsible for the
fiscal management, reporting, and compliance needs of the Center and for ensuring adherence with regulatory
requirements. The Core will further promote resource sharing and scientific exchange between Center
investigators, IDeA and non-IDeA programs, and the scientific and broader community by: (1) making the
Center’s research resources known and widely available; (2) organizing regular Center symposia, training, and
mentoring activities, and workshops on emerging topics in the field of molecular epidemiology; and (3)
educating and engaging diverse stakeholders to inform research priorities for the Center. The Core will work
collaboratively with the Center for Program Design and Evaluation to rigorously evaluate and monitor the
progress and achievements of the Center to enhance effective and timely operations, identify obstacles, and
create lasting and sustainable solutions. The Center Director, Associate Directors, and Center Coordinator will
comprise the leadership team who will report to the Provost and Dean of the Geisel School of Medicine, and
together with accomplished leaders and biomedical scientists, will direct the activities of the Core. An External
Advisory Committee of internationally recognized scientists, a Community Advisory Board of key stakeholders,
and institutional leaders in research, health care delivery, and diversity, equity, inclusion, and belonging
representing Dartmouth, the Dartmouth Health system, and the Dartmouth Cancer Center will provide
guidance to the Center. By fostering discoveries and synergies with local, regional, and national partners and
by being responsive to the IDeA Program, NIH-Wide Strategic Plan, NIH Scientific Workforce Diversity Office,
and other major initiatives, the Core will accelerate the Center’s impact in the field of molecular epidemiology to
improve human health lifelong.